CAP-IT CRI U54 ADMINISTRATIVE CORE

Admin Core: Project Summary/Abstract
A significant overall goal of CAP-IT is to identify and validate immunologically targeted agents for precision
prevention of individuals with increased cancer risk. The CAP-IT Center for RNA Immunoprevention (CRI)
Administrative Core (AC) mission is to ensure that research project/Core teams maintain focus on this overall
goal. The AC will rapidly perform administrative functions that would otherwise serve as rate-limiting bottlenecks,
including IRB/IACUC regulatory compliance and the establishment of MTA/DTAs between multiple project sites.
The AC will integrate CRI U54 into the CAP-IT network and drive intra-network as well as international
collaborations. To ensure CRI's scientific rigor and excellence, we have assembled a scientifically and
administratively outstanding CRI External Advisory Board, including the 2021 Lasker Award winner Dr. Drew
Weissman (U. Penn). The AC shall also seamlessly integrate genomic databases and emerging technology as
shared resources (such as liponanoparticle RNA vaccines and immunopeptidomics) with the CAP-IT U24 DRCC.
1